Multi-Vendor Multi-Site Novel Accelerated MRI Relaxometry

PROJECT SUMMARY/ABSTRACT
This urgent competitive revision responds to NIAMS Notice of Special Interest (NOSI) NOT-AR-23-015. The
parent study (NIAMS R01 AR077452) aims to develop novel quantitative MRI techniques (accelerated MR T1ρ
and T2 mapping) to evaluate cartilage compositional changes and early degeneration in patients after anterior
cruciate ligament reconstruction (ACLR), a population at high risk of developing post-traumatic osteoarthritis
(PTOA). In this study, we aim to explore the mechanisms in musculoskeletal (MSK) pain and identify novel
imaging (knee and brain) markers for pain after ACL injury and surgery, and at early PTOA. The proposed
study will significantly expand the scope of the parent study from only focusing on structural changes (‘disease’)
to one evaluating patient symptoms (‘illness’, in particular pain) in OA. With a novel multi-modal approach that
includes advanced knee and brain MRI, our group will, for the first time, investigate central neural system (CNS)
alterations in pain post orthopaedic injury/surgery, and in early PTOA. The study outcomes will provide critical
preliminary data to formulate specific hypotheses for MSK pain, and will develop novel imaging techniques that
can be utilized for future large-scale studies of pain mechanisms following orthopaedic injury/surgery and in
OA/PTOA, an under-investigated area with pressing clinical needs. As such, the proposed study is aligned with
the NOSI Goal A: Generate supporting evidence towards a future innovative study or new scientific direction in
pain research in musculoskeletal diseases, in the areas of interest of novel pain imaging technologies.
OA affects 30+ million people in the US and 300+ million people worldwide. It presents tremendous health and
socioeconomic burdens with health care costs and work loss. Pain is the major factor that significantly impairs
quality of life, leads to disability, and prompts patients for clinical visits and eventually total joint arthroplasty for
OA. Opioid prescriptions for severe OA/PTOA pain and pain after orthopaedic injury are common, which
constitutes a significant contribution to the national opioid crisis due to its high prevalence. A better
understanding of the mechanisms of post-injury/surgery and OA/PTOA pains and identifying biomarkers that are
associated with or predict MSK pain, the gap the proposed study aims to fill, will provide useful guidance on
developing novel therapeutic targets for pain relief in OA and other MSK disorders. The proposed study presents
a significant and timely expansion of the parent study. It will leverage the resources from the parent study and
provide a unique opportunity to investigate relationship between joint structural damages, CNS alternations, and
pain in a novel early OA model (PTOA, after orthopaedic injury and surgery). The study outcomes will provide
valuable insights to MSK pain mechanisms, help identify new treatment targets for pain relief in this
huge patient population, and eventually help with providing scientific solutions to battle against the ever-
increasing opioid epidemic in the US.

Public health relevance
NARRATIVE/RELEVANCE Pain is the predominant symptom in osteoarthritis (OA), the most prevalent joint disease and a leading cause of disability; however, the pain mechanisms in OA are not fully understand and the current pain management in OA is not sufficient. The proposed study aims to explore pain mechanisms in OA with advanced brain and knee MRI, using a novel, early OA model - post-traumatic OA (PTOA) in patients after acute orthopaedic injury. A better understanding of post-injury and OA/PTOA pain mechanisms is essential for identifying new treatment targets, and for developing novel therapeutic strategies to improve care for this huge and ever-expanding patient population.